Core A-Administrative Core

Core A - Project Summary
Current treatment for thoracic aortic aneurysms (TAA) usually consists of drugs to reduce blood pressure or
surgical intervention. Thus, TAAs present an unmet medical need. In this application, Altered
Mechanotransduction as a Therapeutic Target for Thoracic Aortic Aneurysm, we propose a novel
mechanism for the initiation and promotion of TAAs based upon cell sensing of the mechanical changes in
their environment. This programmatic grant will focus on elucidating whether our hypothesis is correct. Core A,
the Administrative Core, will be in charge of administrative oversight of all aspects of this Program Project
Grant (PPG). As such Core A will monitor and promote the overall scientific progress by organizing joint lab
meetings, annual retreats, electronic exchange of data, Executive Committee member meetings, and
interactions with both the Scientific Advisory Board (SAB) and the Internal Advisory Board (IAB). Core A will
monitor the financial transactions of the individual components and insure that NIH guidelines are followed.
The Administrative Core also will monitor all other regulatory elements of the program with respect to insuring
that the individual components remain in compliance and will report to the NIH any problems, changes, or new
initiatives. The Administrative Core will organize and provide to the NIH a Progress Report each year, as well
as a final Progress Report at the end of the funding period, based upon the individual reports supplied by the
component PIs.